Epidemiology of Ovarian Cancer in African-American Women

DESCRIPTION (provided by applicant): Ovarian cancer is the most lethal of gynecologic malignancies. Although African-American women have lower incidence rates than white women, their five-year survival rates are lower. To date, there has been little research on ovarian cancer in African-American women. In 1993, an analysis involving 110 cases and 365 controls was the first published report describing ovarian cancer risk factors in African-American women. An editorial accompanying this report called for further research on ovarian cancer in African-Americans, however there has been little progress in this area in the past fifteen years. In the international Ovarian Cancer Association Consortium, women of African descent comprise fewer than 300 of the more than 12,000 cases from 18 case-control studies, including 144 cases from our North Carolina Ovarian Cancer Study (NCOCS). Within the NCOCS, we have found evidence suggesting differences between African-Americans and whites in certain ovarian cancer risk factors including CAG repeats in the androgen receptor (AR) gene and anthropometric characteristics. Although these findings are intriguing, we have been unable to confirm them because of the paucity of data on African-American women in other studies. The purpose of this application is to establish a multi-center case-control study involving nine geographic regions within the United States to study the etiology of ovarian cancer in African Americans. The specific aims are: 1. To establish the infrastructure to recruit 1000 African-American women with invasive epithelial ovarian cancer and an equal number of age-matched controls. 2. To determine how risk factors for ovarian cancer in African-American women are similar or different to established risk factors for white women. We will calculate population attributable fractions to determine if differences in the prevalence of risk factors (e.g. reproductive characteristics or obesity) can account for racial differences in ovarian cancer incidence. 3. To evaluate genetic risk factors for ovarian cancer, focusing on concordance or discordance of results with genes that have been reported to be associated with ovarian cancer in white women in studies from large consortia or genome-wide association studies (GWAS). 4. To obtain information on treatment and outcome for ovarian cancer cases. We will analyze patterns of care and assess factors associated with obtaining treatment consistent with recommended standards for therapy. We also will be positioning ourselves to study predictors of survival among African-American ovarian cancer patients. The proposed study will fill an important gap in research on ovarian cancer in African-American women. Not only will we explore risk factors and prognostic characteristics that have been established as important in white women, we will investigate associations with factors that may be specific to African Americans. The large sample size and the diverse populations represented will provide critical insight into the similarities and differences in ovarian cancer risk factors between African-American and white women and may contribute to a better understanding of the poorer survival experienced by African Americans.

Public health relevance
PUBLIC HEALTH RELEVANCE: Although the epidemiology of ovarian cancer has been well-studied among Caucasian women there is very little known about risk factors for ovarian cancer among African-Americans. This is largely due to the sparse enrollment of African Americans in existing epidemiologic studies. The purpose of this study is to enroll 1,000 ovarian cancer cases and 1,000 controls of African American ethnicity from 9 geographic regions in the U.S. to comprehensively evaluate known and suspected epidemiologic and genetic factors for ovarian cancer in this population. The collection of treatment and follow-up data will set the stage to address the disparity in ovarian cancer survival among African-American women diagnosed with ovarian cancer compared to whites. This study will provide new insight into both the etiology and prognosis of ovarian cancer in African-American women. Although the epidemiology of ovarian cancer has been well-studied among Caucasian women there is very little known about risk factors for ovarian cancer among African-Americans. This is largely due to the sparse enrollment of African Americans in existing epidemiologic studies. The purpose of this study is to enroll 1,000 ovarian cancer cases and 1,000 controls of African American ethnicity from 9 geographic regions in the U.S. to comprehensively evaluate known and suspected epidemiologic and genetic factors for ovarian cancer in this population. The collection of treatment and follow-up data will set the stage to address the disparity in ovarian cancer survival among African-American women diagnosed with ovarian cancer compared to whites. This study will provide new insight into both the etiology and prognosis of ovarian cancer in African-American women. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Ovarian cancer is the most lethal of gynecologic malignancies and although relatively rare in incidence, it is the fifth most common cause of cancer death among women behind lung, breast, colorectal and pancreas.13 African-American women have lower incidence rates but poorer five-year survival rates compared to white women.14 Although some improvement in five-year survival rates for ovarian cancer has been observed for white women in recent decades (from 37% in 1975-77 to 45% in 1996-2003), there has been no improvement among African-American women (43% in 1975-77 and 38% in 1996-2003).14 To date there has been little research on ovarian cancer etiology or outcomes in African-American women. In 1993, an analysis involving 110 cases and 365 controls from seven case-control studies was the first published report describing ovarian cancer risk factors in African-American women.15 Although an editorial accompanying this report called for further research on ovarian cancer in African Americans, there has been little progress in this area in the past fifteen years.16 In the international Ovarian Cancer Association Consortium (OCAC), women of African descent comprise fewer than 300 of the more than 12,000 cases from 18 case-control studies, including 144 cases from our North Carolina Ovarian Cancer Study (NCOCS). Within the NCOCS, we have found differences between African Americans and whites in certain ovarian cancer risk factors including CAG repeats in the androgen receptor (AR) gene and anthropometric characteristics.17,18 Although these findings are intriguing, we have been unable to confirm them because of the paucity of data on African- American women in other studies. To address the lack of knowledge regarding ovarian cancer among African-American women, we have established a collaboration involving investigators at nine institutions in areas with relatively large numbers of African Americans in the population (North Carolina, South Carolina, Georgia, Alabama, New Orleans, New Jersey, Ohio, Illinois, and Detroit) to conduct a population-based, case-control study. We propose a multi- center study to gather risk factor information on a large number of African-American ovarian cancer cases and controls that will allow us to make meaningful assessments of etiologic risk factors for African Americans. Further, we will obtain treatment and outcome information to evaluate prognostic factors in ovarian cancer cases. The specific aims of this application are: 1. To establish the infrastructure to recruit 1000 African-American women with invasive epithelial ovarian cancer and an equal number of age-matched controls. 2. To determine how risk factors for ovarian cancer in African-American women are similar or different to established risk factors for white women. We will also calculate population attributable fractions to determine if differences in the prevalence of risk factors (e.g. childbearing patterns or obesity) can account for racial differences in ovarian cancer incidence. 3. To evaluate genetic risk factors for ovarian cancer in African-American women, focusing on concordance or discordance of results with genes that have been reported to be associated with ovarian cancer in white women in studies from large consortia or genome-wide association studies (GWAS). 4. To obtain information on treatment and outcome for ovarian cancer cases. This information will be used to analyze patterns of care and to assess factors associated with obtaining treatment consistent with recommended standards of therapy. We also will be positioning ourselves to study predictors of survival among African-American ovarian cancer patients. The proposed multi-center study will fill an important gap in research on ovarian cancer in African-American women. Not only will we explore risk factors and prognostic characteristics that have been established as important in white women, we also will investigate associations with factors that may be specific to African Americans. In addition to addressing etiologic issues, we will gather information on symptoms, access to care and treatment patterns that will allow us to evaluate how these characteristics may contribute to their lower five-year survival. The large sample size and the diverse populations represented will provide critical insight into the similarities and differences in ovarian cancer risk factors between African-American and white women and may contribute to a better understanding of the poorer survival experienced by African Americans. Acronyms Commonly Used in This Application EMSI Examination Management Services, Inc LMP Low Malignant Potential RCA Rapid case ascertainment GWAS Genome-wide Association Studies NCOCS North Carolina Ovarian Cancer Study RDD Random Digit Dialing KRC Kreider Research and Consulting OCAC Ovarian Cancer Association Consortium